Scaling up: A multi-site trial of e-SBI for alcohol use in Pregnancy

Nearly 1 in 10 pregnant women in the U.S. report past-month alcohol use. Strong evidence connects prenatal
alcohol exposure with a spectrum of conditions known as Fetal Alcohol Spectrum Disorders (FASDs), with
consequences including reductions in brain volume, neurochemical and connectivity-related abnormalities,
executive functioning deficits, and preterm birth. The burden of these consequences is disproportionately
borne by African-Americans. Screening, Brief Intervention, and Referral for Treatment (SBIRT) has been
recommended as a key intervention for pregnant women by the American College of Obstetricians &
Gynecologists and the National Task Force on Fetal Alcohol Syndrome/Fetal Alcohol Effect. SBIRT has clear
advantages, including (a) its proactive and universal approach; and (b) its use of a single motivational session
that is brief enough to be acceptable to a high proportion of patients, even among those with little interest in
treatment. Unfortunately, provider time, training, and fidelity are tremendous obstacles for SBIRT
implementation, and implementation challenges are associated with reductions in effectiveness. Technology-
delivered SBIRT (e-SBIRT) may address these obstacles. e-SBIRT requires far less time and training on the
part of providers, facilitates disclosure, and can be disseminated with perfect fidelity. In the first randomized
trial of e-SBIRT with pregnant women, we developed a single-session e-SBIRT that received high satisfaction
ratings and yielded odds ratios in the medium range for alcohol abstinence and a positive birth outcome. A
subsequent trial with women in a reproductive health setting showed this approach to be equivalent to person-
delivered SBIRT and superior to enhanced usual care, at far less cost. This exciting potential, however, must
be optimized and validated carefully prior to implementation. The proposed study will build upon the pilot trial
by testing whether the intervention reduces alcohol use among pregnant women screening positive for alcohol
risk. We will also use intervention optimization techniques (Multiphase Optimization Strategy, or MOST) to
evaluate the extent to which intervention effects can be enhanced by adding subsequent booster sessions via
participants’ own mobile devices, and/or tailored text messaging. Specifically, we will (a) finalize booster
session and text message content with iterative participant feedback, and (b) randomly assign pregnant
women screening positive for alcohol risk (N = 384) to a 3 (no brief intervention; one session; or one session
plus two boosters) X 2 (SMS present or not present) factorial trial. The primary analysis will test for dose-
response effects of the e-intervention on alcohol use during pregnancy. Secondary analyses will examine main
and interaction effects of tailored text messaging, as well as intervention effects on birth outcomes. Exploratory
analyses will examine theory-driven mediators and moderators of intervention efficacy, as well as intervention
effects on additional drinking-related outcomes (e.g., days of binge use). If successful, the proposed study
would yield an optimized, practical, and readily disseminated method for prevention of FASD.

Public health relevance
Alcohol use during pregnancy is the only cause of Fetal Alcohol Spectrum Disorders (FASDs), which have lifelong health consequences for affected children, and which cost the healthcare system billions annually. The technology-based approach we have developed shows great promise and is by the most practical and feasible approach to FASD prevention yet proposed. This study will help confirm its promise and will evaluate potential ways to increase its efficacy.